Context, Subjective and Cognitive Experiences with Patterns of Tobacco and Cannabis Co-Use in Young Adults

Co-use of tobacco and cannabis has been increasing, especially among young adults in the US, with more than
20% of young adults aged 18-24 reporting use of both substances in the past month. There is growing evidence
that co-use of these substances increases the health consequences and problematic psychosocial outcomes of
either alone, and that use of one product increases the probability of use and failure to stop the other. Co-use is
a broad term and may encompass using both substances within a given time frame (e.g., past month), within a
given episode (concurrent use), in sequence (chasing), or mixed together in the same delivery device (co-
administration). Until recently, co-use was also generally limited to combustible methods, either smoking each
product separately or combining them (e.g., in blunts or spliffs). With the increase in electronic nicotine delivery
systems (ENDS) as well as the increase in states legalizing recreational cannabis, there are new options for co-
use, and ENDS devices that vape e-liquids containing nicotine are becoming more popular methods to consume
cannabis. Although research on co-use is growing, there have been numerous methodological limitations of
prior work, including a lack of detailed data about differences in specific patterns of co-use and modes of delivery,
especially given the rising popularity of alternative tobacco products, as well as a reliance on survey data. Less
is known about the factors that may contribute to the different patterns of co-use in young adults, that may
maintain co-use, and that may be associated with different outcomes. The overall goal of this study is to examine
the situational, momentary factors associated with the different patterns of tobacco and cannabis co-use, how
they may vary by delivery mode, and how they are associated with changes in behavioral outcomes (e.g.,
dependence, changes in rates of use, problem behaviors). This project will use ecological momentary
assessment (EMA) to gather in-depth, real-time naturalistic reports of 425 young adult (aged 18-25) tobacco and
cannabis co-users’ daily experiences and product use behaviors. Across two waves of EMA, we will capture
episodes in which young adults use each product alone as well as when they use them concurrently (during the
same episode), either in a common delivery device (e.g., blunt or vaporizer) or in succession. We will examine
how the proximal context in which the combination of product use occurs and the individual's subjective, affective,
and neurocognitive reactions to those use experiences vary by delivery mode (combustible or vaporized) and
individual characteristics, and how these factors influence future tobacco and cannabis use patterns. Knowledge
gained will provide needed evidence about the behavioral and neurocognitive consequences of co-use use that
will help better inform prevention, intervention, and policy approaches to reducing harms of both products. This
project is also timely in that its data collection occurs in a state (Illinois) that will have just legalized recreational
cannabis use (effective January, 2020).

Public health relevance
Co-use of tobacco and cannabis has been increasing, especially among young adults. Recent changes in the popularity of electronic nicotine delivery systems (ENDS) as well as in the growing number of states legalizing recreational cannabis use increase the public health concern related to the upsurge in co-use. The overall goal of this study is to examine the situational, momentary factors associated with the different patterns of tobacco and cannabis co-use, how they may vary by delivery mode, and how they are associated with changes in behavioral outcomes (e.g., dependence, changes in rates of use, problem behaviors) – data which will be helpful for informing prevention, intervention, and policy approaches to reduce harm from both products.